Non-deletional CD8+ T cell tolerance

Summary
Immunological tolerance prevents autoimmune disease by deleting self-reactive T cell clones or impairing
their function. While there is much know about how CD4+ self-reactive T cells become anergic or acquire
suppressive functions, there is less known about non-deletional forms of CD8+ tolerance. The proposed
research builds on our previous findings regarding CD8+ T cell tolerance to the melanocyte antigen Trp2,
where non-deletional tolerance is prominent. The paucity of CD8+ T cells that react to a given antigen like
Trp2 has presented a challenge to acquiring deeper mechanistic understanding. Here we employ two new
TCR single chain transgenic models where either deletion or non-deletional tolerance prevails, and the
frequency of Trp2 reactive clones is sufficiently high to allow mechanistic studies. Our approach will employ
single cell genomics analysis (scRNAseq and scATACseq) to define the gene-regulation that inhibits non-
deleted self-reactive CD8+ T cells. Further experiments will use deep sequencing of the TCRα repertoire and
generate TCRα retrogenic models to define how the repertoire is shaped by self-antigens and provide
functional classification of different self- reactive clones into 4 types: imperfectly deleted high-avidity clones,
low-avidity anergized clones, low avidity non-anergized clones and “dangerous” clones that evade tolerance
mechanisms altogether. Finally, we will use an established model of vaccination-induced vitiligo to
determine which types of tolerance put animals most at risk of autoimmune disease when provoked by
inflammation. This work will test the central hypothesis that while self-reactive CD8+ T cell clones with the
highest avidity for self are purged from the repertoire, other self- reactive cells survive and are epigenetically
repressed to maintain tolerance.

Public health relevance
Narrative Human autoimmune disease arises from failures of tolerance induction. This proposal will study the fundamental properties of how tolerance is induced in the CD8+ T cells, particularly when the mechanism is not clonal deletion.